Longitudinal Assessment of Driving after Mild TBI in Teens

Project Summary/Abstract This document is not required for the supplement RFA since the abstract from the Parent R01 is included in the Research Strategy section.

Public health relevance
Project Narrative This document is not required for the supplement RFA the Narrative from the Parent R01 remains the same.